Regulation of Renal Tubular Mg2+ Handling by MUC1 and Lactation

PROJECT SUMMARY
Magnesium is critical for physiology. Deficiency influences bone health, promoting osteoporosis. Despite its
importance, and in contrast to other essential minerals, little is known about systemic regulation of Mg2+ balance.
Our goal is to identify mechanisms used by the kidney to modify urinary Mg2+ excretion. Lactation depletes bodily
Mg2+ stores and activates Mg2+ conservation in the kidney. As such, lactation provides a unique setting for
exploring mechanisms modulating Mg2+ reabsorption in the nephron. This proposal explores mechanisms of
lactation-associated Mg2+ conservation (LAMC) at systemic, tissue, cellular, and molecular levels.
At the systemic level, we hypothesize that renal tubular parathyroid hormone receptor (PTHR) signaling
stimulates renal tubular changes in lactation. Lactation-induced changes in gene expression in the nephron are
highest for genes in segments expressing the PTHR. PTHR signaling in lactation is stimulated by PTH-related
peptide secreted by the mammary gland. We will determine whether lactation-associated kidney changes
depend upon PTHR signaling using a selectively kidney PTHR-deficient mouse.
At the tissue level, we hypothesize that lactation remodels the nephron. In lactation, cells in a Mg2+-transporting
nephron segment, the distal convoluted tubule, enhance expression of cyclin D1, suggesting cell proliferation.
This could enhance surface area for Mg2+ reabsorption. Lactation-induced changes in tubule segment length
and cell number will be explored using 2D stereometry, 3D microscopy, and single nuclear RNA-Seq.
At the cellular level, we hypothesize that LAMC depends upon expression of the Mg2+-selective ion channel,
TRPM6. Among known magnesiotropic genes, Trpm6 is unique in being upregulated in lactation. We will
determine whether increased Trpm6 mRNA reflects a larger TRPM6-expressing cell population versus
increasing the number of copies per cell. We will determine whether lactation enhances TRPM6 ion channel
activity. A signaling pathway that influences LAMC is indicated by our observation that the glycoprotein MUC1,
expressed in the distal nephron, is required for LAMC. A human MUC1 variant is associated with
hypomagnesemia. We find that this variant impairs stimulation of EGFR activity by MUC1. Because EGFR
stimulation is known to enhance TRPM6 activity, we will determine whether MUC1 modulates TRPM6 activity
through the EGFR signaling pathway.
At the molecular level, we have determined that inhibition of AKT, an effector within the EGFR signaling pathway,
impairs activation of TRPM6. We have identified putative phosphorylation sites within TRPM6, and we will
determine whether mutation of these sites influences stimulation of TRPM6 by MUC1 and EGFR signaling.
These studies will provide insights regarding mechanisms that drive Mg2+ reabsorption in the kidney tubule and
interventions to improve Mg2+ balance to improve bone health.

Public health relevance
NARRATIVE Magnesium is an essential mineral that is critical for bone density, but very little is known about how the body regulates magnesium absorption and excretion. Lactation represents a stressful physiologic period during which female mammals must provide large quantities of bone minerals, including magnesium, to offspring in the form of breastmilk. This project explores the physiologic changes that occur in the kidney in lactation to provide a better understanding of how the body regulates levels of magnesium and other essential minerals.